Emerging role of glymphatic clearance in Huntington's disease

Project Summary
Huntington's disease (HD) is a neurodegenerative disorder that presents with progressive motor, psychiatric,
and cognitive symptoms leading to early disability and mortality. Although significant advances have been
made in identifying pathogenic pathways and screening of potential drug targets, no treatments to delay the
onset or slow the disease progression exist yet. Thus, there is a need for fresh perspectives on the disease
pathogenesis to discover novel therapeutic targets and to facilitate treatment development for HD. This
proposal’s foundation is rooted in the discovery of impairment of the “glymphatic system” in HD brain.
Glymphatic system is a brain-wide perivascular network that facilitates the exchange of interstitial fluid and
cerebrospinal fluid and clears waste products from the brain. This drainage system is supported by aquaporin-
4 (AQP4) water channels which present with high density in perivascular astrocytic endfeet membranes:
termed AQP4 polarization. AQP4 polarization requires presence of a functional protein complex composed of
a key protein, α1-syntrophin (SNTA1). While multiple independent studies have speculated that the glymphatic
system may play a role in the clearance of neurodegenerative disease-relevant proteins, there is limited direct
evidence available on how this system is altered in HD, and whether its disruption contributes to HD pathology
and disease manifestation. We developed a molecular MRI technique, dynamic glucose-enhanced MR
imaging. Using this MRItechnique, we discovered that D-glucose clearance is significantly reduced in a mouse
model of HD, and glymphatic clearance is impaired prior to brain pathology and motor deficits. We also found
that AQP4 loses its polarization in the HD brain and SNTA1 protein levels were reduced in HD brains. Based
on these findings, we hypothesize that loss of perivascular AQP4 polarization impairs glymphatic function,
consequently preventing mutant HTT clearance and accelerating HD neuropathology and disease progression.
Aim 1 is to define whether glymphatic impairment precedes the development of pathology and behavioral
deficits in HD mice. Aim 2 is to determine whether loss of perivascular Aqp4 polarization by Snta1 knockdown
accelerates HD-like neuropathology and behavioral deficits in HD mice. Aim 3 is to evaluate whether
overexpressing Snta1 or combined with Aqp4 improves glymphatic function in HD mice and attenuates mHTT
accumulation and rescue HD manifestation. This project will reveal a mechanistic basis for identifying new
therapeutics as well as potential biomarkers for HD.

Public health relevance
Huntington's disease (HD) is a neurodegenerative disorder that presents with progressive motor, psychiatric, and cognitive symptoms leading to early disability and mortality. No treatments to delay the onset or slow the disease progression exist yet. This project will provide fundamental insights into the role of the glymphatic system in HD and may reveal a mechanistic basis for identifying new therapeutics as well as potential biomarkers for HD.